Inhibitors of ENPP1 for the treatment of hepatocellular carcinoma

PROJECT SUMMARY
This research aims to improve treatment outcomes for liver cancer patients (hepatocellular carcinoma, HCC) by
identifying the most effective inhibitors of ectonucleotide pyrophosphatase-phosphodiesterase 1 (ENPP1) in
HCC models. HCC is the most prevalent form of liver cancer, with a low survival rate and poor treatment outcome.
Unfortunately, current therapies for HCC are effective in only a small minority of patients, and many who initially
respond eventually progress. This presents the ongoing critical need for novel, improved therapeutic strategies
against HCC. Recently, there has been a growing interest in ENPP1 as an anti-cancer agent. ENPP1 hydrolyzes
cyclic GMP-AMP (cGAMP), a messenger molecule that upon release by cancer cells activates the innate immune
system. By degrading cGAMP, ENPP1 prevents this immune activation. Compared to other cancer types, HCC
expresses particularly higher levels of ENPP1, contributing to a cold tumor phenotype characterized by reduced
immune cell infiltration and limited responses to immunotherapy. ENPP1 inhibition protects against cGAMP
hydrolysis, leading to cGAMP accumulation and consequently activation of antigen-presenting cells, which in
turn results in an effective anti-tumor immune response and tumor regression. Thus, we hypothesize that
treating HCC with an ENPP1 inhibitor will reprogram the tumor microenvironment to yield greater
responses to immunotherapy. Riboscience’s clinical compound RBS2418, the first-in-class ENPP1 inhibitor,
has already demonstrated exceptional safety and clinical benefit, i.e., improved progression-free survival, in
patients with advanced metastatic cancers in a Phase 1a/1b clinical trial at a wide range of tested doses.
Riboscience has recently generated a series of second-generation ENPP1 inhibitors that demonstrate improved
potency in vitro compared to RBS2418. Due to the differences in their physical properties, which affect their in
vivo distribution, these inhibitors exhibited varying levels of efficacy across different cancer models. Thus, to
mitigate the risks associated with developing ENPP1 inhibitors for HCC care, it is first crucial to test and compare
the ENPP1 inhibitors rigorously to identify the most effective one for further combination and mechanistic studies.
The Ho laboratory at John Hopkins has recently developed mouse models of HCC with varying responses to
anti-PD1 immunotherapy. These models are characterized by different levels of T cell and myeloid subtype
infiltration within the tumor immune microenvironment and also exhibit wide-ranging expression of cGAMP
synthase (cGAS) and ENPP1. Thus, we will leverage these unique models to accomplish the following aims: 1)
Identify the best ENPP1 inhibitor for treating HCC; 2) Determine the best treatment combinations of current
Standard-of-Care (SOC) for HCC with ENPP1 inhibition; 3) Determine the immune responses to ENPP1 inhibitor
alone or in combination with SOC therapies to gain mechanistic insights and predict patient response.
Identification of the optimal ENPP1 inhibitor and the most effective combination strategy with SOC therapies in
HCC will greatly benefit patients with HCC who exhibit limited response to current therapies.

Public health relevance
PROJECT NARRATIVE Our goal is to improve current patient response against hepatocellular carcinoma (HCC) by incorporating novel inhibitors of ectonucleotide pyrophosphatase-phosphodiesterase 1 (ENPP1), an enzyme that is markedly overexpressed in HCC and negatively regulates anti-cancer immune response. Riboscience has successfully advanced an ENPP1 inhibitor, RBS2418, to Phase 1a/1b and the clinical results have demonstrated that RBS2418 can fully inhibit ENPP1, improve survival and is very well tolerated in patients with advanced metastatic cancers who have failed all other approved treatment options. Here we propose to test RBS2418 along with three potent ENPP1 inhibitors recently generated by Riboscience, in the HCC models exhibiting varying responses to anti-PD1 immunotherapy established by Ho lab, with the goal of finding the most effective treatment strategy in HCC.